The function of injury-specific macrophages in acute kidney injury

Acute kidney injury (AKI) is defined as an abrupt, and often reversible, decline in kidney function that is
characterized by a decrease of urine output, an increase in creatinine, or both. The ischemia reperfusion injury
(IRI) model most effectively recapitulates the pathophysiological conditions observed following AKI.
Mechanistically, post-ischemic tubular epithelial cells (TECs) undergo necrosis and secrete damage
associated molecular patterns (DAMPs), initiating proinflammatory responses by recruiting monocytes,
neutrophils, dendritic cells and other immune cells. Prolonged inflammation results in further damage to tubular
cells, and eventually CKD. Data from our lab and others has identified macrophages as a key contributor to the
injury and repair process after IRI; however, a detailed description of macrophage phenotype at a cell-by-cell
level after IRI has not been performed and represents a significant gap in knowledge. To address this gap in
knowledge, we generated a comprehensive single-cell RNA (scRNA) sequencing dataset of macrophages at
early, intermediate, and late stages post IRI. Using this dataset, we identified two injury-specific macrophage
clusters: one predominant during the early inflammatory phases (injury-specific macrophage 1 or ISM1), and
the other emerging during the reparative phase of IRI (injury-specific macrophage 2 or ISM2). A detailed
analysis revealed that ISM2 highly expressed Triggering receptor expressed on myeloid cells 2 (Trem2), a
phagocytic receptor involved in anti-inflammatory signaling. Temporal analysis revealed that Trem2 expression
begins 2 days post injury and persists until day 28. CellChat analysis predicted that ISM2 promote tubular
repair after injury by producing reparative ligands including IGF1 that bind to cognate receptors on injured
TECs. Igf1 has previously been associated with improved kidney function after injury by activating cell survival
and cell cycle in an ERK/MAPK and Akt/Rb dependent manner. Based on these data, I hypothesize that the
TREM2 receptor is required for transition of macrophages from a pro-inflammatory to pro-reparative
state, and that ISM2 derived Igf1 promotes tubular epithelial cell repair after injury. In this application, I
will test these hypotheses through a mixture of in vivo and in vitro techniques. There are currently no FDA
approved therapies to treat AKI, or to prevent the AKI to CKD transition. Treatments for patients developing
CKD are palliative in nature and limited to dialysis and transplant, both of which pose a significant health care
burden. Thus, there is an urgent need to develop new therapies to treat AKI and CKD. An understanding at the
molecular level of the AKI-to-CKD transition will aid in the development of effective treatments. Further, the
comprehensive training plan will provide me with the skills necessary to become an independent investigator
study the function of macrophages after AKI.

Public health relevance
Data from our lab and others has identified macrophages as key contributors to the injury and repair process after ischemia-reperfusion induced acute kidney injury (AKI), but a detailed description of macrophage phenotype at a cell-by-cell level after AKI has not been performed and represents a significant gap in knowledge. Using single-cell sequencing datasets I identified two injury-specific macrophage clusters; a detailed analysis revealed that one of them (termed ISM2) highly expressed Triggering receptor expressed on myeloid cells 2 (Trem2), a phagocytic receptor involved in anti-inflammatory signaling, in addition to expressing pro-reparative ligands such as Igf1. In this application, I will study the function of these macrophages in AKI, and how they communicate with tubular epithelial cells to influence the injury and repair process.